Administration Core

Abstract/Summary – Admin Core
The Administrative Core will be responsible for the overall management of the MNORC, its
Cores and the Weight Management Program. Charged with setting ambitious goals and
objectives, MNORC will continuously refine its operations by consulting with its membership,
leveraging advice from Internal and External Advisory Committees, and interacting with other
P30 grants at the University of Michigan and NORCs nationwide. The Administrative Core will
carefully monitor resources, prioritize MNORC activities and ensure that essential information is
reported to both internal and external stakeholders, including NIDDK staff.
The MNORC Administrative Core, through the Core’s Working Group, will oversee all
Enrichment Program and the Pilot and Feasibility Grant Program, ensuring that cost-share
funds are properly allocated to support the most promising investigators. The Core will also
ensure that agreements between the administrative entities who have agreed to co-funding will
be properly executed and documented. The Administrative Core will oversee content for a
website for investigators and the public to promote MNORC activities. Finally, acting as a
bridge to the research community at the University of Michigan, the Administrative Core will
identify new members, match them with core capabilities and nurture collaborations among UM
researchers with interests in obesity and/or nutrition research.